Defining microtubule cytoskeleton regulatory pathways in development and disease

Title: Defining microtubule cytoskeleton regulatory pathways in development and disease
P.I. Kassandra Ori-McKenney
Project Summary:
Cellular architecture is governed by the organization of cytoskeletal networks and determines the functional
output of a cell. It is therefore essential to understand the regulatory mechanisms of cytoskeleton organization
as a cell develops, changes, or maintains its internal structure, because altering these processes can hinder
cell function and ultimately lead to pathological conditions. In particular, disrupting the activities of microtubule-
associated proteins (MAPs) is correlated with a range of neurodevelopmental disorders, neurodegenerative
diseases, and cancers. In published and preliminary data, we have found that a subset of MAPs exhibit diverse
binding behaviors on the microtubule lattice and differentially affect microtubule motors and tubulin
posttranslational modifications, highlighting an essential role for MAPs in gating access to the lattice.
Furthermore, we have observed that cells utilize specific MAPs to remodel their microtubule landscapes in
order to efficiently adapt to changes in their environment. We are only beginning to understand how MAPs in
their unaltered states control tubulin posttranslational modifications and microtubule-based transport under
different cellular contexts, but MAPs themselves are heavily modified by a handful of kinases whose regulatory
effects remain unclear. We have identified DYRK1a kinase as a key regulator of the microtubule cytoskeleton
due to its role in phosphorylating multiple MAPs. DYRK1a is involved in a range of cellular processes and is
implicated in many neuropathologies and cancers; however, the downstream molecular mechanisms of this
kinase are largely unexplored. The goal of this project is to dissect the multiple layers of regulation of
microtubule-based processes by studying the biochemical and genetic relationships between kinases, MAPs,
tubulin posttranslational modifications, and motors both in vivo and in vitro. We aspire to construct a
comprehensive network to elucidate the multiple ways in which disease-relevant kinases and MAPs modulate
the microtubule cytoskeleton during different cellular processes. To accomplish these goals, we will use an
interdisciplinary approach combining in vivo and ex vivo imaging techniques with in vitro biochemical assays.
We will utilize epithelial cell lines to study how cells tailor their microtubule cytoskeletons for specific functions,
the dendritic arborization neurons of the Drosophila peripheral nervous system to study neuronal
morphogenesis, dendritic pruning, and polarized transport, and mammalian neuronal cell culture to analyze
patterns of MAPs, tubulin posttranslational modifications and cargo transport under various conditions. To
complement these in vivo experiments, we plan to perform in vitro reconstitution experiments using TIRF
microscopy with purified MAPs, microtubule motors, tubulin modifying enzymes, and kinases in order to
elucidate their individual and collective effects on MAP binding, microtubule dynamics and microtubule-based
transport. We endeavor to comprehensively dissect MAP networks at the protein level and at the cellular level,
in order to understand how these pathways contribute to a diversity of human pathologies.

Public health relevance
Title: Defining microtubule cytoskeleton regulatory pathways in development and disease P.I. Kassandra Ori-McKenney Project Narrative: DYRK1a kinase has been implicated in a range of intellectual disability disorders and neurodegenerative diseases. Little is known about the molecular network of this kinase and the distinct roles it plays during different cellular functions, but we have found that DYRK1a regulates the microtubule cytoskeleton by directly phosphorylating several microtubule-associated proteins (MAPs). This proposal seeks to delineate the pathways that orchestrate the dynamic microtubule cytoskeleton by combining live imaging of cellular and organismal systems with in vitro biochemical reconstitution assays. The overall goal of this project is to elucidate the multifaceted mechanisms of the DYRK1a-MAP network in regulating essential microtubule-based processes in order to provide insight into the contribution of this pathway to multiple human diseases.